Optimizing Renin Angiotensin System Blocker Use among Veterans with Kidney Disease

Background: Prevalence of moderate to severe chronic kidney disease (CKD) is 70% higher in veterans than
the general population. Annual cost for non-dialysis dependent CKD population care increased to $18 billion in
FY 2016 for Veterans Administration. Angiotensin-converting enzyme inhibitors (ACEI) and angiotensin II
receptor blockers (ARBs) are considered standard of care for CKD patients as they improve cardiovascular
outcomes and retard progression to end stage kidney disease. Among veterans with diabetes and CKD, only
66% are on ACEI or ARB with significant variation across facilities. Among the ~34% not receiving ACEI or
ARB, it is unclear whether they were started on these agents, started but stopped due to an adverse event or
never started on ACEI or ARBs for e.g. due to clinical inertia. ACEI/ARB discontinuation is associated with an
increased need for dialysis and a higher risk of mortality. In this proposal, we plan to understand the proportion
of underuse of ACEI/ARB attributed to side effects versus clinical inertia using structured datasets and
unstructured provider text notes, and barriers to initiation and re-initiation (after being discontinued) of
ACEI/ARB. Based on these learnings, we propose to pilot test a communication aid in patient aligned care
teams (PACTs), which will assist clinicians to initiate or reinitiate ACEI/ARB therapy in CKD patients.
Significance: Successful implementation of the proposed study will help us (a) understand the reasons for
lack of initiation of ACEI or ARB and their discontinuation (b) successfully develop, refine and pilot test a
communication aid to optimize ACEI/ARB use among CKD population. These could reduce kidney disease
progression, an improvement in cardiovascular outcomes and potential cost savings for the VA system.
Innovation: The project utilizes both structured and unstructured data using natural language processing
(NLP) to understand the full context for underutilization of ACEI or ARBS. Furthermore, we utilize innovative
qualitative techniques and human factors bests practices to study and address this important gap in care.
Aim 1: To examine reasons for lack of initiation and discontinuation of ACEI or ARBs among CKD patients
based on structured data and automated information extraction using NLP. Aim 2: To conduct semi-structured
interviews with PACT providers and patients at two tertiary care facilities and their community-based outpatient
clinics (CBOCs) to further understand the reasons for lack of initiation or discontinuation of ACEI or ARBs
among veterans with CKD. Based on these interviews, we will refine a succinct communication aid targeted
towards PACT providers which will allow them to effectively initiate and/or reinitiate ACEI/ARB in CKD patients
(including those with prior side effects). Aim3: To pilot test a communication aid for clinicians to improve
initiation of ACEI or ARB or re-initiation of ACEI or ARB after being discontinued due to an adverse event.
Methodology: For Aim 1, we will identify CKD patients using VA structured datasets and will randomly
partition them into training and a test set. We will then train our NLP system to achieve a target sensitivity and
specificity of >90% compared with manual chart review to assess reasons for lack of initiation/reinitiation of
ACEI/ARB. For Aim 2, we will conduct semi-structured patient and provider interviews to understand barriers
towards lack of initiation or reinitiation of ACEI or ARBs in CKD patients. We will then refine the content of a
communication aid (using a human factors expert) for use during the pilot trial in Aim 3. For Aim 3, we will
conduct a pilot trial. All PACT providers at the intervention sites will receive the communication aid to improve
initiation of ACEI/ARB or reinitiation of ACEI/ARB after being discontinued due to an adverse event. At the
usual care sites, PACT providers will only receive a quarterly report of the proportion of their CKD patients not
on an ACEI/ARB. Our primary outcome is the change in the proportion of CKD patients receiving ACEI/ARBs.
Next Steps: If our pilot study in Aim 3 is successful, then we will aim towards a system-wide implementation of
our communication aid throughout our VISN to improve ACEI or ARB use in veterans with CKD.

Public health relevance
ACEI/ARB therapy reduces cardiovascular events and progression to end-stage kidney disease in patients with chronic kidney disease (CKD) and albuminuria. We have shown that ACEI/ARB therapy is underused in veterans with CKD. This could be related to clinical inertia but could also be related to ACEI/ARB associated side effects which may not be well captured in structured VA datasets. The objectives of this proposal are to (a) identify reasons for suboptimal ACEI/ARB in CKD patients use using both structured data and provider text notes using novel informatics techniques (Aim 1) (b) understand patient and provider perspective on ACEI/ARB use in CKD and refine a communication aid targeting providers to improve ACEI/ARB use in CKD patients (Aim 2) and (c) pilot test an intervention (Aim 3) to improve ACEI/ARB use in veterans with CKD using the communication aid refined in Aim 2. Our results will identify strategies to improve ACEI/ARB use in high-risk veterans with CKD, who stand to derive the most benefit from this life saving therapy.